Immunomodulatory effects of topical artesunate on cervical intraepithelial neoplasia 2/3.

Despite the advent of prophylactic vaccines to prevent infection with oncogenic human
papillomaviruses (HPVs), the incidence of cancers caused by HPV remains high, both in the US and
world-wide. Intraepithelial HPV cancer precursors present an opportunity for cancer interception:
they are relatively accessible and clinically indolent, making it possible to carry out window-of-
opportunity, proof-of-concept treatment trials without compromising standard of care. However,
while trials testing therapeutic HPV vaccines to treat CIN2/3, the precursor to HPV cervical cancers,
have shown partial success, their focus has been upon generating HPV-specific immune responses.
HPV oncogenes driving transformation present rational antigenic targets, yet little is known about
mechanisms of histologic regression. The projects we propose will focus on the lesion itself. There is an
increasing appreciation of the role of microbes at the gut and other niches in cancer, and evidence of
dysbiosis in the context of CIN. Currently, our understanding of the functional contributions of
tumor microbiomes to tissue susceptibility to treatment is incomplete, in part owing to difficulty in
obtaining longitudinal data from human interventional trials. We will analyze subject-matched,
clinically annotated specimens collected before, during, and after treatment, from a novel
interventional clinical trial testing treatment of CIN2/3 with a repurposed, topical formulation of
artesunate, a plant-derived compound used as part of frontline treatment for acute malaria.
(NCT02354534) The clinical outcomes from were highly impactful; histologic regression (HR)
occurred in 19/28 (68%) of treated subjects -- more than twice the expected rate of spontaneous
regression observed over the same timeframe. We will now build on this promising clinical data to
determine tissue-based biomarkers of response to ART, as well as phenotypes of treatment resistance,
with the intent of developing next-generation interventions to treat CIN and HPV-related
malignancies at other anatomic sites. We will capitalize on a unique extant biorepository, and an
outstanding team of expert scientists to study constituents of the tumor microenvironment (TME),
including tumor and immune cells, microbes, and metabolites, in subject-matched samples of
responders vs non-responders. Insights gained will inform strategies to overcome ART treatment
resistance. Finally, this work will begin to address an enormous unmet clinical need for accessible
treatment options for incipient HPV cancers, which now are either excisional or ablative, and require
sequential access to health care infrastructure. An inexpensive, self-administered, non-surgical
treatment without cold chain requirements would be transformative.

Public health relevance
PROJECT NARRATIVE Intraepithelial HPV lesions are generally clinically indolent, and are relatively accessible, making it possible to carry out window-of-opportunity, proof-of-concept treatment trials without compromising the standard of care. This work will provide opportunities to hypothesize causal relationships between the cervicovaginal metagenome and metabolome, and treatment responses, in subject-matched specimens obtained before, during, and after treatment with artesunate vaginal inserts for CIN2/3, the precursor to squamous cervical cancers.